Patient-Reported Diagnostic Safety Events in Ambulatory Care Settings: A National Survey of Systemic Influences, Disparities and Persisting Consequences

Project Summary
Diagnostic errors, delays, and related problems have been shown to be widespread in outpatient settings.
Patient and family reports of these experiences offer a vital perspective on the scope, causes, and
consequences of these mishaps. Yet, to date, information regarding patient experiences has been quite limited
in the U.S., largely involving inpatient treatment or limited samples of patients from a few health systems or
self-selected patient advocacy groups.
This project would provide the first nationally representative estimates of Americans’ experiences with and
concerns about diagnostic safety in ambulatory care. Deploying a survey incorporating several innovative
survey methods, the study would (a) more reliably identify patient-reported safety events than in past surveys,
(b) more fully elicit patient- and family-reported narrative accounts of those events, and (c) more consistently
track the extended consequences of diagnostic problems. Data would be collected from 3,300 U.S. households
that experienced diagnostic problems between 2020 and 2025. A sample this size makes possible
comparisons across multiple settings (including newly emergent sites like urgent care clinics) and among
different subgroups of patients, including those most marginalized historically.
Because establishing an accurate, timely diagnosis is often challenging for clinicians and confounding to
patients and their families, diagnostic problems are common in every healthcare system. But American
healthcare financing and delivery systems are especially fragmented. We hypothesize that this fragmentation
elevates the risks and harms of diagnostic breakdowns, particularly in outpatient settings. The study will test
these hypothesis for three forms of insecurity induced by fragmentation (a) coverage insecurity, linked to
anxieties about what healthcare insurance will cover, (b) guidance insecurity, emerging from patients’ difficulty
identifying a clinician who can help them navigate the diagnostic process, and (c) process insecurity, emerging
when multiple clinicians and care settings are associated with the diagnosis, leaving patients with inconsistent
expectations for how the diagnostic process will unfold. Because all three forms of insecurity vary greatly within
the American healthcare, we can both empirically assess the impact of fragmentation on diagnostic outcomes
and estimate the potential benefits of reducing these three forms of fragmentation.

Public health relevance
Project Narrative This project would provide the first nationally representative estimates of Americans’ experiences with and concerns about diagnostic safety in outpatient settings. Deploying a set of innovative survey methods, data about patient experiences will be collected from 3,300 households to generate a more inclusive, complete and balanced portrait of the contemporary state of diagnostic safety in American healthcare. Using this data, the project team will then assess the impact of health system fragmentation on the prevalence and consequences of diagnostic mishaps, leveraging these results to predict potential benefits from addressing three aspects of fragmentation to improve diagnostic safety and equity in the future.